Epigenetic Mechanisms That Drive Genetic Risk in Juvenile Arthritis

Abstract
We aim to move the field of genetics as applied to juvenile idiopathic arthritis (JIA) away from the
identification of genetic associations and toward a mechanistic understanding of how genetic variants exert
risk-conferring effects. We will accomplish two major tasks now facing the field: (1) identification of the
variants that exert the biological effects that confer risk (the “causal variants”); (2) identification of the genes
whose expression levels are altered by those variants (the “target genes”). In accomplishing these aims,
we will also elucidate mechanisms through which those variants alter gene expression and cellular
functions.
One of the striking findings from GWAS for many complex traits, including rheumatic diseases such as
JIA, is the frequency with which disease-associated genetic variants appear in the non-coding genome. As
in other complex traits, the JIA genetic risk loci are highly enriched for H3K4me1/H3K27histone marks,
epigenetic signatures frequently associated with enhancer function. This finding has led to the hypothesis
that genetic risk in JIA impinges on enhancer function, leading to transcriptional abnormalities that can be
observed in peripheral blood cells. In this application, we focus on CD4+ T cells, which our preliminary data
suggest are among the cells likely to be impacted by causal genetic variants in JIA.
In Aim 1, we will identify causal variants based on distinct biological properties. We will identify histone
quantitative trait loci (hQTLs) in CD4+ T cells of children with JIA, i.e., regions where genetic variants are
associated with differences in read depth on H3K4me1/H3K27ac Cut-and-Run sequencing. We will use the
same approach as that previously used by our co-investigator, Dr. Gaffney, in his investigations into the
genetics of systemic lupus. We will then identify the variants within the hQTLs that alter DNA topology, a
critical determinant of regulatory function. Finally, from variants that pass both screens, we will use a
massively parallel reporter assay (MPRA) to identify those variants within the hQTLs that have a significant
influence on gene expression.
In Aim 2, we will identify the target genes within the JIA risk haplotypes. The underlying premise of these
studies is that, although the causal variants may not impact the nearest gene, the majority of relevant
interactions will occur within the same topologically associated domains (TADs). Using Cut-and-Run data
that we generate in Aim 1 as well as H3K27ac HiChIP data and supplemented by our published CTCF
ChIPseq/HiChIP data, we will identify interactions between H3K27ac-marked regions on the risk haplotypes
and gene promoters, focusing on those within CTCF-anchored TADs. Knowledge of the 3D chromatin
structure, patient genotype, and RNAseq data will then allow us to identify the likely target genes of variants
on the risk haplotypes.

Public health relevance
Narrative This project aims to understand how genetic factors increase the risk for juvenile idiopathic arthritis (JIA), one of the most common chronic disease conditions in children. In this study, we will examine how genetic variants alter a class of genome regulators called enhancers, which are like rheostats that allow cells to turn genes up or down depending on the circumstances. We will then identify genes that are affected by altered enhancers, an important step toward developing new therapies and improving outcome for children with this disease.